STUDY OF ORAL RS 25560197 IN PATIENTS WITH CONGESTIVE HEART FAILURE

The objective of this study will be to evaluate the safety and tolerability of single and multiple (10 day) dose oral administration of RS-25560 in patients with CHF (NYHA class II or III) and elevated plasma norepinephrine levels.